Mechanisms of antibiotic persistence in a mouse model of systemic infection

PROJECT SUMMARY
Systemic bacterial infections are a major cause of morbidity and mortality globally, and antibiotic
treatment failures constitute a major global health issue. In recent years, there has been increasing attention to
previously underappreciated mechanisms of antibiotic treatment failure, specifically the role of phenotypically
distinct bacterial subpopulations which fail to be eliminated. During an infection, individual bacterial cells are
differentially exposed to a wide range of host-derived stressors. This can result in the emergence of
phenotypically distinct subpopulations with reduced susceptibility to antibiotics – a phenomenon termed
antibiotic persistence. Antibiotic persistence poses a significant therapeutic challenge; surviving bacterial
subpopulations can promote long-term and relapsing infections. The development of new therapeutic
strategies for antibiotic persistent infections is currently limited by major gaps in our understanding of the
mechanisms responsible for the development and maintenance of antibiotic persistence in the context of a
mammalian infection.
Our laboratory has developed a mouse model for prolonged antibiotic treatment of a systemic bacterial
infection, as a system for studying antibiotic persistence within the host environment. Mice are inoculated
intravenously (i.v.) with the Gram-negative bacterium Yersinia pseudotuberculosis (Yptb). Yptb is a natural
pathogen of humans and rodents, and there are many genetic tools well-established in Yptb. Upon i.v.
inoculation, the bacteria disseminate to deep tissue sites (primarily the spleen), where they form structures
referred to as microcolonies by 48 hours post-infection. Microcolonies consist of a bacterial center surrounded
by host immune cells (neutrophils and monocytes/macrophages). Bacterial centers within each microcolony
are complex and dynamic populations, with distinct bacterial subpopulations, making them a powerful model
for studying phenotypic heterogeneity. The central hypothesis of this project is that exposure to host-
derived stressors will induce persistent bacterial phenotypes, which will be further induced and
maintained during the course of antibiotic treatment, until antibiotic levels wane. Here we will use a new
bacterial RNA sequencing approach, along with existing genetic tools to study antibiotic persistence
mechanisms in our newly developed prolonged treatment mouse model. Through this project we hope to
provide mechanistic insight to inform the development of new treatment strategies, including combination
therapies to specifically target multiple populations.

Public health relevance
PROJECT NARRATIVE During infection, the emergence of bacterial subpopulations with reduced antibiotic susceptibility represents a major therapeutic challenge. The proposed research will investigate the mechanisms by which this phenomenon, termed antibiotic persistence, develops and is maintained using a mouse model of systemic infection with the natural human and rodent bacterial pathogen, Yersinia pseudotuberculosis. By expanding our understanding of antibiotic persistence mechanisms, this work will contribute to the development of new treatment strategies for persistent bacterial infections.